Efficacy of novel reservoir-host targeted bait formulations against a tick-borne pathogen

Lyme disease is the most common tick-borne illness in the US. Currently, there are no vaccines available to
prevent Lyme disease and antibacterial therapy is the treatment of choice. The disease is caused by a
spirochete, Borrelia burgdorferi, which is maintained in nature through an enzootic cycle involving a tick vector
and a variety of vertebrate hosts. Regulation of gene expression in B. burgdorferi in response to environmental
cues prevalent in these highly divergent hosts is critical for pathogen survival and transmission between the
tick vector and vertebrate hosts. Deletion of Borrelia host-adaptation Regulator (BadR) and site-specific
replacement of 8 critical residues of Carbon Storage Regulator A result in dysregulated borrelial strains that
hyper-express a variety of lipoproteins. Purified Borrelial Lipoproteins (PBLs) from these strains confer
protection when administered via parenteral route against challenge with B. burgdorferi infected Ixodes
scapularis nymphs. Consistent with the RFA-AI-19-037 “Targeted Prevention of Tickborne Diseases”, this
proposal is directed at evaluating PBLs from hyper-expression borrelial mutants as a bait-formulation to
develop a reservoir-targeted approach to interrupt the natural history of B. burgdorferi infection using
experimental (C3H/HeN) and reservoir (Peromyscus leucopus, white-footed mouse) mouse models of Lyme
disease. Use of PBLs in their native conformation circumvents the need to express these antigens as
recombinant proteins in heterologous systems or limitations in their reconstitution to reflect their proportions on
the borrelial surface. The central hypothesis of this proposal is that oral administration of PBLs protects
reservoir hosts against Bb challenge via ticks and interferes with the natural history of infection via Ixodes
scapularis ticks. This hypothesis will be tested with 3 specific aims. In Specific Aim 1, correlates of protective
immunity induced by PBLs against B. burgdorferi will be determined. Humoral immune response, levels of
borrelicidal antibodies and levels of protection against B. burgdorferi challenge via ticks induced in C3H/HeN or
P. leucopus mice following oral or parenteral administration of PBLs will be compared. In Specific Aim 2, the
levels of PBL-induced reduction in B. burgdorferi burden in ticks will be determined. The ability of naïve tick
larvae and nymphs fed on PBL-immunized mice to acquire and transmit B. burgdorferi to naïve mice will be
ascertained to establish a strategy to interfere with the natural history of infection. In Specific Aim 3, several
adjuvants and novel strains of B. burgdorferi expressing lipoproteins with properties to increase the potency of
a single dose, oral, reservoir bait vaccine will be evaluated. These studies are novel in exploiting the
components of genetically defined borrelial mutants in conjunction with adjuvants that increase the potency of
PBLs administered as bait formulations to interfere with natural life cycle of Lyme disease pathogen. Overall,
the proposed strategies will help in developing a vaccine platform exploiting genetically modified avirulent
organisms or their components to block one or more tick-borne pathogens.

Public health relevance
PUBLIC HEALTH RELEVANCE: Borrelia burgdorferi (Bb), the causative agent of Lyme disease, is the most prevalent arthropod-borne infectious agent in the US and causes significant morbidity and extensive health care costs in endemic areas where the disease is prevalent. The proposed studies are directed at evaluating genetically defined mutants that hyper-express a number of lipoproteins as reservoir bait vaccines to limit or eliminate the survival of Bb in experimental and reservoir mouse models. Several adjuvants will be evaluated for stimulating protective immune response against Lyme disease pathogen as a single dose, oral, reservoir-targeted vaccine to interrupt natural history of infection leading to a reduction in the incidence of Lyme disease.